Core 2: Data Science Core

CORE 2, DATA SCIENCE – SUMMARY
The purpose of the Data Science Core (Core 2) is to provide a comprehensive, multi-disciplinary resource with
expertise in biostatistics and bioinformatics. Members of the Core 2 will collaborate closely with investigators
from each project in translating their biological hypotheses into testable statistical hypotheses and address the
corresponding aims at all levels of investigation. This consists of designing laboratory and animal experiments,
storing and managing the resulting data, statistical and bioinformatics data analyses using well-established and
pre-tested analysis pipelines, mining and integration of public data, and formulating new hypotheses based on
discoveries arising from exploration and visualization of the integrated data. The Core 2 serves as a focal
point from which investigators may be assisted with statistical and bioinformatics expertise for planning,
management, and analysis of their studies. It also develops, tests, and implements various statistical and
computational techniques, including mathematical modeling with special focus on cancer research. Types of
research supported include basic science, translational research, and omics data analysis. The large volume of
information to be generated in the proposed research projects and cores requires computer-guided approaches
for coordination of efforts and management of data. The primary role of the Core 2 will include establishing
a centralized relational database system and data management structure that facilitate entry, storage and
retrieval of all data generated by the program projects and permits the controlled exchange of information
across the projects and cores. De-identified information will be available to all investigators associated with this
Program Project Grant (PPG). Due to the sensitive nature of the information stored by the Core 2, we will
take extensive precautions to protect the confidentiality of participants. All IRB and HIPAA regulations will be
strictly enforced. By providing data access to investigators, sharing technical capabilities, and ensuring the quality
of the data, the data management component of this core will facilitate achievement of the project aims and
encourage exploratory analyses beyond those stated.

Public health relevance
CORE 2, DATA SCIENCE – NARRATIVE The Data Science Core serves as a comprehensive, multi-disciplinary resource of expertise in biostatistics and bioinformatics to assist investigators from all projects to design their experiments, manage and maintain the large volume of data, make inference regarding the stated aims, and formulate new hypotheses based on discoveries arising from exploration and visualization of the integrated data.